Neurobiology of Varicella Zoster Virus

DESCRIPTION (provided by applicant): Varicella zoster virus (VZV) causes chickenpox, after which the virus becomes latent in cranial nerve, dorsal root and autonomic nervous system ganglia along the entire neuraxis. Decades later, virus reactivation produces zoster (pain and rash restricted to 1-3 dermatomes) in about 1 million Americans annually. Zoster is often followed by postherpetic neuralgia (PHN, chronic pain), as well as retinitis, myelitis and vasculopathy, which are significant causes of blindness, paralysis and death. Although zoster vaccine reduces the incidence of zoster by 50% over a 3-year period, even if everyone over age 60 received it, there would still be 500,000 cases of zoster and 200,000 of PHN annually. Thus, as the elderly population increases in number, the incidence of zoster and its attendant neurological complications is still likely to increase. In 1983, we first proved that VZV is latent in human ganglia. Our subsequent analyses of >6,000 human ganglia from >700 randomly autopsied subjects showed that the entire virus genome is present, maintained as a histone-coated circular episome with a variable abundance of VZV DNA, and that VZV gene expression is restricted and regulated epigenetically without transcription of VZV micro-RNA. Nonetheless, mechanism(s) underlying VZV gene expression during latency have been hampered by the lack of a model that faithfully recapitulates the molecular events in latently infected human neurons. We have now developed an in vitro model in which human neural stem cells were induced to differentiate to >90% neurons, as evidenced by immunohistochemical staining. After infection with cell-free VZV, the neurons can be maintained for weeks in the absence of a cytopathic effect. We hypothesize that these VZV-infected neurons can be used to study VZV latency, thus obviating the need for thousands of human ganglia, and enable analyses not currently possible in human ganglia. Our goal is to prove that the in vitro differentiated neurons are latently infected with VZV after which we will use them to further study VZV latency. Specifically, we will isolate VZV-infected differentiated neuronal cells by optimized laser capture microdissection (LCM) and determine the purity of LCM-captured infected neurons by RT-PCR with neuron- and glial-specific primers (Aim 1). We will verify that these neurons are latently infected by showing that the physical state of VZV DNA and VZV gene transcription in LCM-captured neurons is the same as in latently infected human ganglia (Aim 2); we will then analyze epigenetics of the VZV DNA; and use GenomeLab Genetic Analysis System to analyze the entire VZV transcriptome (Aim 3). An in-depth understanding of the mechanism(s) of VZV gene expression in latently infected human neurons will lead to experiments designed to prevent the cascade of events leading to VZV reactivation, a cause of serious neurologic disease and blindness, particularly in the rapidly increasing elderly and immunocompromised populations.

Public health relevance
PUBLIC HEALTH RELEVANCE: An in-depth understanding of how varicella zoster virus lives in latently infected human nerve cells is prerequisite to developing strategies that prevent the cascade of events leading to virus reactivation, a cause of serious neurologic disease and blindness, particularly in the rapidly increasing elderly and immunocompromised populations. An in-depth understanding of how varicella zoster virus lives in latently infected human nerve cells is prerequisite to developing strategies that prevent the cascade of events leading to virus reactivation, a cause of serious neurologic disease and blindness, particularly in the rapidly increasing elderly and immunocompromised populations. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Varicella zoster virus (VZV) causes chickenpox in 4 million children annually, after which the virus becomes latent in cranial nerve, dorsal root and autonomic nervous system ganglia along the entire neuraxis. Decades later, as VZV-specific host immunity declines, virus reactivates spontaneously, resulting in zoster (pain and rash restricted to 1-3 dermatomes). Zoster affects about 1 million Americans yearly. Postherpetic neuralgia (PHN, chronic radicular pain) develops in >40% zoster patients (400,000 - 600,000 Americans/year). Other serious neurological complications of zoster include retinitis, cerebellitis, myelitis and vasculopathy, which are significant causes of blindness, paralysis and death. By the year 2030, 22% of Americans (65 million people) will be over age 65, and the over-85 population will triple to >8 million. The incidence and severity of zoster can be viewed as a continuum in immunodeficient individuals, ranging from a natural decline in VZV-specific immunity with age, to more serious host immune deficits encountered in transplant recipients and patients with cancer and AIDS. Although a zoster vaccine can reduce the incidence of zoster by 50% over a 3-year period, even if everyone over age 60 received it, there would still be 500,000 cases of zoster and 200,000 of PHN annually. Thus, as the elderly population increases in number, the incidence of zoster and its attendant neurological complications is still likely to increase. In 1983, we first proved that VZV is latent in human ganglia. Our subsequent analyses of >6,000 human ganglia from >700 randomly autopsied subjects showed that the entire virus genome is present, most likely maintained as a histone-coated circular episome with considerable variability in VZV DNA abundance, and that VZV gene expression is restricted and regulated epigenetically without transcription of VZV micro-RNA. RT- PCR detected transcripts mapping to VZV ORFs 21, 29, 62, 63 and 66 in latently infected human ganglia, of which ORF 63 transcripts were the most frequent and abundant. To more precisely define the epigenetics of VZV DNA and total extent viral gene expression during latency in neurons, we developed a model of VZV- infected neurons in vitro. Neural stem cells were induced to differentiate into more than 90% neurons, as evidenced by immunohistochemical staining for MAP2a, but not for GFAP or CNPase. Most importantly, when infected with VZV, the neuronal cells remained viable and could be maintained for weeks in the absence of a cytopathic effect, in contrast to other human cells in tissue culture that were killed in a few days by the same cell-free VZV inoculum. Thus, we hypothesize that these neurons in vitro are latently infected with VZV and can be used to study VZV latency. To prove that these neurons are latently infected and to further study VZV latency, we propose the following Specific Aims: Aim 1. Isolate neurons cultured in vitro after VZV infection and demonstrate their purity. VZV-infected differentiated neural stem cells on polyethylene naphthalate membranes will be isolated using the third- generation Veritas laser capture microscopy (LCM) instrument which cuts through the membrane around selected cells, enabling isolation of neurons. The purity of LCM-captured neurons will be determined on lysates from LCM-captured cells by RT-PCR with primers specific for neurons and glial cells. Aim 2. Verify that these neurons are latently infected by showing that the physical state of VZV DNA and VZV gene transcription in LCM-captured neurons is the same as in latently infected human ganglia by: (a) determining that the entire VZV DNA molecule is present in infected neurons using PCR; (b) showing that the configuration of VZV DNA in infected neurons is circular or concatameric by quantifying internal sequences compared to terminal sequences using real-time PCR; and (c) that VZV gene transcription is limited. Aim 3. Extend studies of the physical state of VZV DNA and VZV gene expression in latently infected neurons by: (a) conducting an epigenetic analysis of VZV DNA in infected neurons by chromatin immunoprecipitation assay; and (b) analyzing infected neurons in vitro for the entire VZV transcriptome by GeXP multiplex PCR. For the first time, it will now be possible to study healthy-appearing neurons in vitro in a well-defined controlled model system of VZV infection. We will be able to rapidly verify and extend 30 years of study on the physical state of viral nucleic acid and virus gene expression in latently infected human ganglia. The impact of an in vitro model of VZV latency is considerable, since it will not only allow studies that would normally require thousands of human ganglia for analysis, but also will permit studies of VZV interaction with the innate host immune response and of differences in apoptotic pathways in neurons vs. non-neuronal cells that lead to VZV latency, studies not possible in human ganglia. An in-depth understanding of how varicella zoster virus lives in latently infected human nerve cells is prerequisite to developing strategies that prevent the cascade of events leading to virus reactivation, a cause of serious neurologic disease and blindness, particularly in the rapidly increasing elderly and immunocompromised populations.